Phage Display for Improved Peptide-Based Tumor Targeting and Imaging Agents

Aggressive forms of cancer are a leading health problem for United States Veterans. While most cancers
are treatable in their earliest forms, gender-related cancers including those of the breast and prostate are
often fatal when diagnosed at advanced and/or metastatic stages. In 2020, these cancers will account for over
75,400 annual deaths in the general population, with morbidity rates significantly higher in the Veteran
population. While most patients initially respond to treatment, they often relapse and develop aggressive and
drug resistant tumors. A promising approach to better detect and treat these types of cancers may be through
development of agents that target drug resistance biomarkers that associate with cancer stem cells (CSCs).
CSCs make up a small proportion of a tumor but drive tumor aggressiveness and drug resistance. There are
few validated CSC biomarkers, and most are not cancer-specific. Our laboratory is at the forefront of new
biomarker and CSC identification using bacteriophage (phage) display. Peptides and antibody (Ab) fragments
that bind the breast and prostate associated Thomsen-Friedenreich carbohydrate antigen, (TF), the lectin
galectin-3 (gal-3) that binds TF and inhibits immune response, and CD444v6 have been obtained. These
antigens are involved in cell adhesion, angiogenesis, immune regulation, and cell signaling, and are thought to
represent CSC biomarkers. Further, we demonstrated that CD44v6 binds gal-3 through TF interaction,
suggesting this triad may represent a novel target to probe CSCs, tumor growth and immune surveillance.
Both Abs and peptides have been used with mixed success in cancer imaging and therapy. In terms of
Abs their large size can cause immunogenic problems and long distribution times that once radiolabeled often
leads to organ and tissue damage. Conversely, peptides, particularly those from phage display are
usually hydrophobic and often suffer from poor affinity and tumor uptake. Two different tacks will be
employed that overcome these drawbacks. A pretargeted “click” chemistry approach which decouples the
tumor-targeting step from the radioimaging or radiotherapy step can be employed. This pretargeted approach
is based on the rapid and highly specific cycloaddition reaction that occurs between the trans-cyclooctene
(TCO) on the tumor by allowing the unlabeled targeting Ab to circulate and bind the target. Subsequently,
injection of a small molecule radiolabeled probe with rapid pharmacokinetics and high affinity for the
pretargeted Ab, will result in higher tumor to normal tissue uptake ratios compared to direct labeled Abs. The
second tack will be to conjugate small peptides to a nanoparticle for multi-peptide display. Cornell prime dots
(C' dots) are a new and well-characterized nanoparticle platform that offer both multimodal-targeted imaging
and therapy, and multiplexing biomarker interrogation. C' dots are silica core-shell PEG nanoparticles that
exhibit favorable clearance from the blood and are primarily excreted through the kidney overcoming extended
circulation times. The tunable surface chemistries and favorable in vivo pharmacokinetics allow C' dots to
overcome many of the dose limiting toxicities associated with current monomolecular cancer therapeutics.
It is hypothesized that the Ab fragments and peptides that target gal-3/TF/CD44v6, coupled with
pretargeting and C'dot multivalent display, will produce theranostic agents for aggressive prostate (PCa) and
breast cancer (BCa). The objectives of this research are to develop: 1) radioimaging and radiotherapeutic
agents of aggressive PCa and BCa tumors, 2) probes that inhibit tumorigenesis leading to reduced
tumor growth and metastasis, and 3) bifunctional molecular therapeutics that increase tumor immune
response through dual targeting with gal-3 and immune checkpoint inhibitors.
Our work will positively impact VA healthcare in that we are developing new targeting agents for detection
and treatment of cancer that will be well tolerated in vivo. This work will help improve the lives of our Veterans
and coincides with BLR&D general goals and special interests of Women's Health and Genomic Medicine.

Public health relevance
This work is relevant to the VA mission in that we are developing new ways to target and treat aggressive forms of breast and prostate cancer that become resistant to standard treatment. We have obtained peptides and antibody fragment probes that bind to the lectin galectin-3 and its carbohydrate ligand Thomsen Friedenreich, and CD44v6 expressed on aggressive/cancer stem cells. These antigens function in key steps in tumorigenic pathways including cell adhesion, signaling, and immune response. Highly novel click chemistries and nanoparticles will be employed to generate multivalent/fluorescent/radiolabeled peptides and Abs to detect aggressive tumors, reduce tumor growth, and increase immune response in vivo. In terms of human health, the probes will improve the standard of care of patients in that they will be well tolerated in humans and radioactive versions will rapidly clear the body avoiding radiation damage. Our studies coincide with VA Healthcare Initiatives employing cancer biology, genomics and women's health issues.